Toward a speech rehabilitation model for linguistically and culturally minor groups: Foreign born immigrants

PROJECT SUMMARY/ABSTRACT
Despite the increasing attention to the “culturally and linguistically diverse (CLD)” communities in research and
clinical practice, monolingual speakers of minority languages living in the United States (US), such as foreign-
born populations who speak a language other than English, have been nearly excluded from speech
rehabilitation. This is mainly because of the assumption that the target language of intervention is English
regardless of the cultural and linguist background of the patients. The goal of the proposed project, framed by
the International Classification of Functioning, Disability, and Health ICF), is (1) to address missing personal
and environmental factors of the foreign-born populations who are in need of speech rehabilitation and (2) to
develop and conduct a small-scale clinical trial that incorporates these missing factors into a speech
intervention program.
For an initial effort, a total of 32 Korean-speakers with Parkinson’s disease (PD) and their families will
participate in the study. To overcome the primary obstacles of delivering speech therapy in Korean, such as the
availability of Korean speech rehabilitation programs in US, we employ two recent rehabilitation delivery models:
telepractice and group therapy. PD participants will receive speech therapy consisting of 16 sessions of 60
minutes duration delivered over four weeks using a telehealth platform. PD families will attend weekly, 1-hour,
family training and support sessions, which will provide family counseling and conversation training. Primary
(speech intelligibility, acoustic measures) and secondary (communication participation, health and well-being)
outcome measures will be obtained from Pre-, Post-, and Follow-up timepoints.
The primary deliverable will be the initial stage for an interdisciplinary speech intervention model for
speakers with communication disorders who cannot receive speech therapy in English. Further, health literacy
among linguistically and culturally diverse groups will be enhanced. The long-term goal is to expand the
number and scope of populations with quality health care access and to develop speech intervention programs
that incorporate sophisticated attention to personal and environmental factors specific to the target clinical
populations.

Public health relevance
PROJECT NARRATIVE The ultimate goal of the proposed study is to establish an interdisciplinary speech intervention model for speakers with communication disorders who cannot receive speech therapy in English in the United States. As a first step, the proposed project aims to develop and conduct a small-scale clinical trial study in which the linguistic and cultural diversity of the participants (Korea-born immigrants with Parkinson’s disease) is taken into account. In recognition of the family-centered decision making (FCDM) among East Asian health service users, families of PD participants will be also regarded as active participants of the intervention program with respect to their communication skills with PD patients and health/well-being.